COMPARISON OF DETOXIFICATION TREATMENT FOR OPIATE ADDICTION

This study is a double-blind, double-dummy comparison of buprenorphine (1-4 mg sl daily), a partial opiate agonist, vs. clonidine (0.2 - 0.9 mg po daily), an alpha-2 adrenergic agonist, in the treatment of acute opiate withdrawal. Sixteen patients are randomly assigned to receive one of the 2 medications for 3 days, followed by 14 days of inactive placebo. Patients are also stratified by degree of opiate dependence, as measured by a cutoff opiate withdrawal score following naloxone challenge (0.4 mg im). Outcome measures include both physiological and psychological signs and symptoms of opiate withdrawal. In addition, optional subprotocols involve measuring vagal and sympathetic tone as reflected in variations in cardiac interbeat interval (in collaboration with the ARC Vulnerability Lab), and cerebral metabolism using positron emission tomography (PET) with 2-F-DG (in collaboration with ARC Neuropharmacology Lab and Hopkins PET Center). To date, 12 patients have completed the study, which is the first direct, controlled clinical comparison of buprenorphine with a standard treatment for acute opiate withdrawal.